INTERACTIONS AMONG GPI-ANCHOR PROTEINS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This project aims to identify interactions among the proteins of the GPI-GnT enzyme complex, as well as interactions between this complex and additional proteins in yeast.